FDA Veterinary Laboratory Investigation and Response Network Cooperative Agreement Program-WA

1 Project Summary: The goal of the CVM Vet-LRN Veterinary Diagnostic Laboratory Program is
2 to complement, develop, and use university, state and federal veterinary diagnostic laboratory
3 resources and expertise in order to increase national laboratory capacity to detect, respond to
4 and recover from a catastrophic animal food/feed contamination event, either microbial or
5 chemical. The program's funding allows provision for equipment, supplies, and personnel;
6 training in standardized testing methodologies; participation in proficiency testing in those
7 methodologies; participation in method enhancement activities to extend analysis capability; and
8 analysis of surveillance and emergency outbreak samples. Vet-LIRN laboratories nationwide
9 strengthen the overall food safety system through increased capacity and capability to detect
10 adulterations affecting animals raised for human consumption or companion animals consuming
11 ingredients used in both animal and human food products. The Washington Animal Disease
12 Diagnostic Laboratory (WADDL) at Washington State University is well positioned to effectively
13 function as a regional laboratory in the CVM Vet-LIRN Veterinary Diagnostic Laboratory
14 Program. Since 1974 WADDL has provided full laboratory diagnostic services (approximately
15 300,000 tests annually), including pathology, microbiology and toxicology, to veterinarians and
16 animal owners throughout the Pacific Northwest. WADDL actively participates in multiple
17 national laboratory networks (Vet-LIRN, USDA-NAHLN, CDC-LRN) and is well practiced in
18 standardized methods, equipment, proficiency testing, electronic reporting, and national disease
19 surveillance programs emphasizing early detection and response. WADDL has a mature
20 laboratory quality system based upon international ISO 17025 laboratory standards, being fully
21 accredited by the American Association of Veterinary Laboratory Diagnosticians laboratory
22 accreditation program since 1978. Using FDA-Vet-LIRN funding during 2012-2017 WADDL
23 successfully participated in sample analysis for surveillance and consumer report investigations,
24 provided proficiency testing, electronic reporting, and quality system implementation, and
25 participated in special projects on companion animal salmonellosis, and methods development
26 and matrix extension for analytical chemistry testing. The laboratory is fully capable and highly
27 competent to participate in FDA/Vet-LIRN key project areas of sample analysis, providing
28 analytical data to support regulatory use, and participating in additional projects regarding
29 method development, validation and matrix extension.

Public health relevance
Project Narrative: The FDA Vet-LIRN Veterinary Diagnostic Laboratory Program enables, nationwide, the analyses of animal diagnostic samples and animal food/drug products. The Program fills a gap for the FDA Office of Regulatory Affairs (ORA) regarding veterinary diagnostic samples that greatly facilitates early detection of and response to animal food/drug adulteration and contamination events. Through the Vet- LIRN program, FDA leverages the expertise of a national system of university, state and federal veterinary diagnostic laboratories to provide additional capacity and capability, obtain veterinary diagnostic information critical to ORA response, and strengthen the overall national food safety system.